Novel gene delivery to modulate the tumor microenvironment and antigen-specific antitumor immunity

Abstract
Technological advancements have yielded novel drug targets and improved cancer detection,
but transformative innovations in treatment modalities are lacking. Leveraging our team's
expertise in gene therapy, breast cancer, cancer immunology, and breast cancer animal and
patient-derived xenograft models, we propose to use recombinant adenovirus with a higher
tumor-specific expression of herpes simplex virus-thymidine kinase (HSV-TK), which is a
suicide gene that causes tumor cell death. We will combine HSV-TK with our immune
checkpoint antibody (i.e. HMR-101) that will specifically target tumor cells, release tumor
antigens and change the tumor microenvironment to be more favorable for immune therapy.
The immunotherapy we are developing will modify cancer-promoting immune cells to become
anti-cancer immune cells. Therefore, an army of anti-cancer immune cells trained to recognize
cancerous cells will mobilize and circulate around the body to destroy metastases. Given the
predominance of tumor-associated immunosuppressive myeloid cells in triple-negative breast
cancer, local delivery of HMR-101 could effectively reprogram the tumor microenvironment to
an anti-tumor immune phenotype. The viral transduction efficiency of our viral vector is very
high at the tumor site with chimeric viral vector (low neutralization antibody), and it will be low
spreading to other organs. This viral vector is safe and approved by the FDA and at low cost
for human use. As such, our intratumoral strategy would allow for maximizing the full potency
of the immunotherapeutic antibody, thus enhancing therapeutic index. We envision this
technology to move forward to clinical trials, strongly supported by the success of our recently
completed STOMP trial for metastatic triple-negative breast cancer or TNBC (NCT03004183,
HSV-TK, radiation, and immune checkpoint therapy on metastatic TNBC). Clinically, we
envision that our intratumor gene delivery of HMR-101 will reprogram the immune system,
prevent patients from relapse, and prolong anti-tumor immunity, thus benefiting patients
receiving immunotherapy. For triple-negative breast cancer patients who typically have dismal
clinical response due to high metastatic rate and recurrence, the potential clinical impact of
our intratumoral viral delivery containing novel immune checkpoint antibody is profound.
Overall, the therapeutic reach of our novel therapeutic regimen is expansive, offering a truly
transformative approach to cancer treatment.

Public health relevance
The intratumoral viral gene delivery containing a novel combination of herpes simplex virus -thymidine kinase gene (HSV-tk) and bifunctional antibody and prolongation of the gene expression may provide a novel and inexpensive therapeutic regimen, offering a truly transformative approach for cancer treatment.